Diversifying and Strengthening Dementia Palliative Care Clinical Trials

Project Summary/Abstract
Alzheimer’s disease (AD) and AD-related dementias (AD/ADRD) are progressive, debilitating, and
terminal illnesses1 that cause significant suffering to individuals and families. Dementia is the sixth
leading cause of death in the United States; 1 in 3 older adults die with a dementia syndrome.
Distressing symptoms -- shortness of breath, pain, neuropsychiatric symptoms, and feeding problems,
are common, and worsen over the disease trajectory. Transitions between care settings increase as
AD/ADRD progresses, often resulting in poorly coordinated and fragmented care. Family caregivers
provide extraordinary emotional and practical support through all stages of illness, resulting in high
rates of caregiver strain, depression, physical illness, and loss of employment. Palliative care seeks to
improve quality of life and reduce suffering by addressing patient and caregiver distress, managing
symptoms, clarifying goals of care and aligning goals with preferences. While in many conditions,
palliative care has been associated with a wide array of beneficial outcomes including improved quality
of life, increased patient and caregiver satisfaction, and cost saving, these outcomes have not been seen
consistently in ADRD. In fact, there is a dearth of evidence to guide clinicians in providing high-quality
palliative care in ADRD. The overall objective of this application is to improve the evidence base for
dementia palliative care interventions by identifying and upskilling dementia and palliative care
investigators in the conduct of rigorous clinical trials focused on improving quality of life for persons
living with dementia and their care partners. Using our experience of training researchers in palliative
care clinical trials and leveraging our strong network of dementia palliative care investigators, we will
seek to a) Identify promising diverse investigators in palliative care, geriatrics and clinical neurosciences
and provide the opportunity for further training in the design, funding, conduct, monitoring/oversight,
ethical performance, and reporting of ADRD palliative care clinical trials; b) Enhance the pipeline of
rigorous, well designed ADRD-PC clinical trials by equipping investigators with a strong foundation in the
conduct of ADRD-PC clinical trials based on the NIH Stage Model, including intervention development,
community-engaged research and implementation science; c) Promote ongoing professional career
development by supporting participants before, during an after a week-long in-person training program;
and d) Create a network for collaboration and sharing of educational resources for clinical trialists in
dementia palliative care.

Public health relevance
Project Narrative More evidence is needed to improve the quality of life of persons living with advanced dementia and their caregivers. This training program will increase the evidence base for dementia palliative care by identifying and training diverse investigators in the design, funding, conduct, monitoring/oversight, ethical performance, and reporting of dementia palliative care clinical trials.